HSR&D Senior Research Career Scientist Award

Dr. Teresa M Damush, a VA HSR&D 8/8ths (15/3) Research Career Scientist at the Indianapolis Roudebush
VAMC is applying to renew her current Research Career Scientist (RCS) award as a Senior Research Career
Scientist (SRCS). During the past 2 decades, Dr. Damush has led and evaluated local, regional, and large
scaled, nationwide implementation interventions of evidence-based practices related to VA specialty care,
neurological (e.g., stroke/TIA and headache) healthcare services in the Veterans Health Administration (VHA).
She has extensive experience in conducting productive collaborations with VA operational partners in quality
improvement initiatives (QUERI) and with HSR&D investigators nationally on key topics (e.g., access) related
to VA priorities. During her current RCS award, Dr. Damush has served as the corresponding Principal
Investigator of two large, VA HSR&D QUERI Implementation Centers: (PRIS-M: Precision Monitoring to
Transform Care (PRIS-M) from 2015-2020 and Expanding Expertise Through E-health Network Development
(EXTEND) from 2020-2025. She also recently completed as PI an HSR&D funded implementation pilot
(TENACITY) testing the delivery of CBT-Headache protocol via telehealth across 3 diverse VAMC contexts for
specialty care headache services. In her SRCS, Dr. Damush plans to expand and elucidate on the effective
implementation strategies to deliver telehealth models of evidence-based care as well as identify effective
spread and sustainment strategies across VHA. In 2023, Dr. Damush applied her implementation strategy
bundle research to understand the implementation of colorectal cancer screening in urban and rural Indiana
healthcare organizations and clinics. Thus Dr. Damush has served as PI/Co-PI on 5 grants during her current
RCS award with funding equaled to over $15 million. She is a nationally (e.g., Rutten-Mayo Clinic) and
internationally (e.g., Sustainability-Lennox in Handbook on Implementation Science; Cochrane Collaboration;
Low Back Pain -Ulm University, Germany) cited researcher. Her implementation research has been featured in
both the VA Virtual Implementation and University-based Journal Clubs. She has presented consistently with
137 peer-reviewed presentations at National Scientific Conferences, cyberseminars and has published 126
peer-reviewed scientific manuscripts including high impact scientific journals. Dr. Damush provides mentoring
to health services researchers and implementation scientists from a variety of disciplines including medicine,
nursing, psychology, engineering, pharmacy, public health, and anthropology. In 2021, Dr. Damush
successfully competed for a VA HSR&D Advanced Learning Healthcare System (LHS) Postdoctoral Fellowship
Program and serves as its Co-Director at the Indianapolis CHIC Coin. Dr. Damush also Co-Directs the VA
HSR&D EXTEND QUERI Center Mentoring Program. Dr. Damush also expanded her chronic pain research to
chronic headache leading the Qualitative and Implementation Core of the Congressional mandated VHA
Headache Centers of Excellence (HCoE) alongside the National VA Director of the HCoEs, Dr. Jason Sico.
Most recently, she has expanded this research to study equitable access to high quality headache care in the
VHA in collaboration with the VA Offices of Health Equity, Emergency Medicine, Neurology, and Primary Care.
With the renewal of the SRCS, Dr. Damush plans to assess the equitable access to high quality, specialty
headache care in VHA to inform, develop, test, and evaluate a Stepped Care Model for Headache
Management (SCM-HM). This line of research holds great potential to bridge current gaps in chronic headache
care and positively impact Veterans’ chronic headache care and quality of life by elucidating and standardizing
clinical pathways across primary care, emergency care and specialty care services.

Public health relevance
The VA Research Career Scientist Award has provided Dr. Damush with the opportunity to expand her implementation research, expand her VA health services researcher collaborations and partnerships, and strengthen her mentoring, leadership and service roles. In the renewed Senior RCS, Dr. Damush would build upon her current VA implementation research to identify evidence-based spread and sustainment strategies and continue co-directing the VA HSR&D Learning Healthcare System Fellowship to help build the skills of early scientists to engage with VA operational partners in the VA Learning Healthcare System. Moreover, she would expand upon her chronic pain research by evaluating the quality and accessibility of equitable specialty headache care and to inform and develop a VA Stepped Model of Headache Care Management.